Characterization of Longitudinal EEG Biomarkers in Chronic Low Back Pain

Project Summary/Abstract
Chronic low back pain (CLBP) is a pervasive disorder affecting up to one-fifth of adults globally and is the
single greatest cause of disability worldwide. Despite the high prevalence and detrimental impact of CLBP, its
treatments and mechanisms remain largely unclear. Biomarkers that predict symptom progression in CLBP
support precision-based treatments and ultimately aid in reducing suffering. Longitudinal brain-based resting-
state neuroimaging of patients with CLBP has revealed neural networks that predict pain chronification and its
symptom progression. Although early findings suggest that measurements of brain networks can lead to the
development of prognostic biomarkers, the predictive ability of these models is strongest for short-term follow-
up. Measurements of different neural systems may provide additional benefits with better predictive power.
Emotional and cognitive dysfunction is common in CLBP, occurring at the behavioral and cerebral level,
presenting a unique opportunity to detect prognostic brain-based biomarkers. Likewise, improvements in
electroencephalogram (EEG) neuroimaging strategies have led to increased spatial resolution, enabling
researchers to overcome the limitations of classically used neuroimaging modalities (e.g., magnetic resonance
imaging [MRI] and functional MRI), such as high cost and limited accessibility. Using longitudinal EEG, this
patient-oriented research project will provide a comprehensive neural picture of emotional, cognitive, and
resting-state networks in patients with CLBP, which will aid in predicting symptom progression in CLBP.
Through this mentored career development award (K23), I will use modern EEG source analysis strategies to
track biomarkers at baseline and 3- and 6-month follow-ups and their covariance with markers for pain and
emotional and cognitive dysfunction. In Aim 1, I will identify and characterize differences in resting-state,
emotional, and cognitive networks between patients with CLPB and age/sex-matched controls. In Aim 2, I will
identify within-subject changes across time and their relationship with clinical symptoms. In Aim 3, as an
exploratory aim, I will apply machine- and deep-learning strategies to detect a comprehensive signature of
CLBP using EEG features from resting-state, emotional, and cognitive networks. Throughout the award period,
I will develop new and advanced skills in understanding CLBP and its comorbidities as well as in EEG signal-
processing strategies, machine-/deep-learning algorithms, career development, and grant writing. To
accomplish the proposed study and training, I have gathered a world-class team of experts in pain imaging,
physiology, psychology, EEG, and statistical learning as mentors. This training will build on my prior
experience in psychophysiology to achieve my long-term goal of becoming an R01-funded investigator focused
on patient-oriented research in chronic pain and psychophysiology.

Public health relevance
Project Narrative Prognostic biomarkers support precision-based treatments yet are lacking for patients with chronic lower back pain. Here, I aim to use advanced electroencephalogram-based neuroimaging strategies to identify and characterize biomarkers of dysfunctional brain networks (resting-state, cognitive, and emotional) in patients with chronic low back pain across time. The information gained from this study will increase our understanding of the neural processes underlying chronic pain and inform future patient-oriented research and solutions.